Small Scale Robotics for Automated Dental Biofilm Theranostics

PROJECT ABSTRACT
Oral biofilm-related infections remain a persistent and costly clinical problem. Existing treatments are unable to
simultaneously kill and physically disrupt biofilms and require manual biofilm removal procedures that are
cumbersome with reduced efficacy in difficult to reach areas such as endodontic canal systems. Furthermore,
options for sample retrieval for diagnostics during clinical procedures are limited. Efficacious, automated
technologies capable of precisely targeting complex anatomical areas are needed to retrieve samples, kill and
remove biofilms, and deliver drugs on site. We propose a novel approach combining nanotechnology and
robotics to develop the first automated system for targeted disinfection, removal, and sampling of endodontic
biofilms. We have designed small-scale robots using catalytic nanoparticles as building blocks that display
tether-free controlled motion with multifunctionality. Our approach utilizes iron oxide nanoparticles (IONPs) with
dual catalytic-magnetic properties that (i) generate bactericidal and biofilm degrading reactive molecules in situ,
and (ii) remove the disrupted biofilm via magnetic-field driven robotic assemblies termed Catalytic Antibiofilm
Robots (CARs). Preliminary data demonstrate that CARs locally remove and collect biofilms with high precision
and efficacy in comparison to conventional treatment, including confined endodontic spaces. By tuning the
magneto-catalytic properties and control of the CARs systems, we will develop robotic device
prototypes that fit the oral cavity for simultaneous endodontic biofilm treatment, removal and sample
retrieval. We propose to further improve IONP-made robots coupled with a clinical electromagnetic controller
to develop two CARs-based oral biodevice platforms. (Aim 1) CAR1s, formed from aggregated IONP, will be
used for catalytic bacterial killing, biofilm treatment, and sample retrieval from root canals for diagnostic analysis.
We will identify key parameters for CAR1s improvement, assessing magnetic control, bioactivity and
visualization/tracking. CAR1s will be evaluated for targeting difficult-to-reach areas, such as C-shaped/curved
canals and isthmus, as well as treating and retrieving biofilms. We will characterize and improve CAR1 control
first using 3D-printed tooth replicas with diverse canal morphologies to improve movement and controllability,
followed by testing our system using ex vivo extracted tooth/typodont and pig jaw models. (Aim 2) CAR2s will
be fabricated by 3D micromolding functional polymers with embedded IONPs for biofilm disruption, retrieval,
and drug delivery at the apical region. We will optimize magnetic control and tracking, antibiofilm activity and
triggered cargo delivery, testing efficacy to remove and retrieve biofilms. We will assess bioactivity using mixed-
species biofilms and maneuverability to the apical region of the root canal recapitulated in 3D-printed teeth and
ex vivo models, while rigorously evaluating the robotic device in geometries suited to the oral cavity with
comparisons against conventional treatment. We expect the outcomes of the proposed studies will lead to the
first robotic biodevice system developed for automated biofilm theranostics for applications in dental medicine.

Public health relevance
Project Narrative We have designed small-scale robots using catalytic nanoparticles as building blocks that display automated and tether-free controlled motion with multifunctionality. These robots can locally kill, degrade and retrieve biofilms with high precision and efficacy. This pioneering approach combining nanotechnology and robotics principles will afford an unprecedented level of endodontic biofilm detection and treatment, and will generate the first instance of robotics devices for automated clinical application in the dental field.